Contribution of BLA-mPFC pathway to risky choice and compulsive cocaine seeking

Project Summary/Abstract
This is a resubmission of a renewal application for an AREA R15 grant to continue research funded in
DA047610 (“Contribution of NMDA NR2B subunit to risky choice and economic demand for cocaine” now titled
“Contribution of BLA-mPFC pathway to risky choice and compulsive cocaine seeking”). The purpose of the
R15 grant is to stimulate research at primarily educational institutions like Northern Kentucky University (NKU)
that support baccalaureate training but are not recipients of major NIH support. Risky choice is characteristic of
several psychiatric conditions, including substance use disorders (SUDs). Substance misuse can be
considered a risky behavior as individuals can become incarcerated for their drug use or can ultimately die
from overdose. Understanding the neurobiology of risky choice is important for designing effective treatment
interventions for individuals that are at risk for developing SUDs. During our current funding period, we have
shown that the GluN2B subunit of the glutamate N-methyl-D-aspartate (NMDA) receptor mediates risky choice
as assessed in the risky decision task (RDT), and it mediates addiction-like behaviors as measured in cocaine
self-administration and in methamphetamine conditioned place preference. Because the RDT uses foot shock
as punishment, determining if a rat displays increased risky choice or insensitivity to shock is difficult. Thus, the
first goal of the current proposal is to use a novel task to measure risky choice. To this end, rats will be tested
in an equivalent expected value (EEV) task, in which reinforcer magnitude and reinforcement probability will be
adjusted across concurrently available reinforcers such that the expected utility (value) of each alternative is
equivalent. Because the expected value is equivalent across reinforcer alternatives, there is no suboptimal
choice. However, risky choice can be measured by the percentage of responses for the lower probability/larger
reward alternative. To further elucidate the neurocircuitry of risky choice, we will determine if chemogenetic
inhibition of medial prefrontal cortex (mPFC)-projecting basolateral amygdala (BLA) neurons and/or BLA-
projecting mPFC neurons decreases risky choice in the EEV task (Specific Aim 1). Specific Aims 2 and 3 will
utilize the same chemogenetic approach from Specific Aim 1 to determine if the reciprocal connections
between the BLA and the mPFC mediate compulsive cocaine seeking and resurgence of cocaine seeking
(model of relapse-like behavior). Renewed funding will allow us to answer these critical questions and will allow
undergraduate students to continue gaining research experience in behavioral neuroscience research at NKU.

Public health relevance
Project Narrative Currently, there are few treatments that are efficacious in treating individuals with disorders characterized by maladaptive risky decision making, including psychostimulant use disorders. The purpose of the proposed research is to determine how chemogenetic inhibition of medial prefrontal cortex (mPFC)-projecting basolateral amygdala (BLA) neurons and BLA-projecting mPFC neurons alter risky decision making and cocaine-seeking behavior. The results of the current proposal will be important because novel interventions that target specific neural circuits (e.g., BLA-mPFC pathway) can be used to better treat those that engage in risky behaviors, including compulsive substance use.